Analgesic and Opioid Sparing Brain Mechanisms of Mindfulness-Oriented Recovery Enhancement for Chronic Low Back Pain

ABSTRACT
Chronic low back pain (cLBP) is the most common clinical pain condition worldwide, and the top
chronic non-cancer condition for which opioids are prescribed. The current opioid crisis in the
U.S. emerged in large part from overuse and misuse of opioids by patients with cLBP. Yet, there
are few evidence-based interventions to reduce opioid use and misuse among patients with
cLBP. Faced with a lack of effective treatment options, some cLBP patients become ensnared
in a downward spiral of opioid dose escalation. Mindfulness-based interventions reduce chronic
pain and opioid dosing. However, lack of mechanistic data has limited the deployment of these
cost-effective and non-pharmacological treatment approaches. Multiple clinical trials indicate
that Mindfulness-Oriented Recovery Enhancement (MORE), a novel mind-body therapy that
integrates mindfulness with other affect regulation techniques, alleviates chronic pain symptoms
as well as opioid use among people with cLBP. Yet, the active brain mechanisms of action
underlying MORE’s analgesic and opioid sparing effects remain unknown. Further, no known
placebo-controlled studies have disentangled the specific neural mechanisms of MORE or other
mindfulness-based interventions for cLBP from nonspecific therapeutic factors like beliefs,
expectancy, and social support. As such, the proposed study will employ one of the most
rigorous control conditions in the mindfulness literature to date—a validated sham-mindfulness
meditation technique combined with supportive psychotherapy (Sham-MORE). Integrating
functional neuroimaging and psychophysics (noxious heat and behavioral pain ratings), the
overarching aims of the proposed R01 study are to a) identify the neural mechanisms
supporting the immediate analgesic effects of MORE (versus Sham-MORE and treatment-as-
usual), and b) to determine if changes in default mode network functional connectivity predict
individual differences in cLBP relief and opioid dose reduction following treatment with MORE.
Ultimately, the proposed work will yield insight into the fundamental neuro-functional processes
mediating the therapeutic effects of mindfulness-based interventions for cLBP, thereby
facilitating the optimization of novel biobehavioral treatments for this highly prevalent and
disabling chronic pain condition that helped to fuel the ongoing opioid crisis.

Public health relevance
PROJECT NARRATIVE Millions of Americans suffer from chronic pain, opioid misuse, and opioid use disorder. New intervention strategies that integrate mindfulness, physical therapy, and/or medications for opioid use disorder (MOUD) are needed to improve health outcomes in these vulnerable patients. To accomplish this aim, we propose the Opioid and Pain Effectiveness research Network for Mindfulness and Integrative Health Intervention Development (OPEN-MIIND), a multidisciplinary research center dedicated to addressing the opioid crisis.